Adapting the Penny Chatbot for Perinatal OUD Patients: COPILOT

PROPOSAL SUMMARY/ABSTRACT
The US opioid crisis has had a significant effect on many populations, not the least of which effected are
perinatal women. The prevalence of opioid use disorder (OUD) among women giving birth in hospitals increased
by 131% from 2010-2017. OUD in pregnancy and postpartum increases the risks for a host of medical
complications and can lead to adverse birth outcomes including preterm delivery and intrauterine fetal demise,
as well as maternal morbidity and mortality. Loneliness and social isolation are also linked to poorer progression
of acute, chronic, physical, and mental conditions, as well as mortality, and are compounded during the perinatal
period (which is defined as pregnancy and the first postpartum year). Both loneliness and social isolation have
been linked to increased opioid use amount, relapse rates, and overdose even when controlling for OUD
treatment, employment, relationship status, and depression.
To address both loneliness and engagement in perinatal and OUD care among perinatal women, we plan
to adapt an existing texting support chatbot, Penny, to make it appropriate for use by women who are pregnant
and postpartum and dealing with OUD. The newly adapted chatbot, Penny COPILOT, will allow for two way
short message service (SMS) messaging using natural language processing to respond appropriately and
accurately to user generated input. In this way, Penny COPILOT feels like texting a friend, as it responds using
real sentences and minimizes awkward confirmatory messages. Our team, in collaboration with the Penn Mixed
Methods Research Lab (MMRL) and Memora Health Technology Company, will use intervention mapping guided
by the Consolidated Framework for Implementation Science. We will conduct a needs assessment, assemble
an advisory board, engage in pretesting to ensure safety and refine content, and pilot test the resultant adapted
Penny COPILOT in a sample of 20 perinatal women with OUD to evaluate acceptability, feasibility, and patient
satisfaction. Our goal is to develop and refine an acceptable, feasible, and satisfactory supportive texting chatbot
to promote patient engagement in perinatal and OUD care and decrease perceived loneliness.

Public health relevance
PROJECT NARRATIVE The perinatal period, defined as the time period during pregnancy and up to one year postpartum, is a vulnerable period for women affected by opioid use disorder, and which may be compounded by loneliness and social isolation leading to an increased risk of relapse, overdose, and even death. Despite recent advances in telehealth programs for postpartum women and for individuals with substance use disorders, no current treatment models exist to integrate maternal perinatal and OUD treatment with an emphasis on loneliness and social isolation. In order to adapt an existing supportive texting chatbot to decrease feelings of loneliness and increase engagement in OUD and perinatal care, we now embark on a study utilizing steps from intervention mapping to identify needs of perinatal women with OUD, develop new content appropriate to our target population, refine the accuracy of the content and messaging, and test the feasibility and acceptability of our new model, the Penny COPILOT.